Focal Adhesion Kinase inhibition for dual targeting of osteosarcoma cells and the tumor microenvironment to prevent metastasis

Project Summary. Despite intensive efforts, outcomes for patients with osteosarcoma (OS), the most common
primary malignant pediatric bone tumor, have not improved since the advent of multi-drug chemotherapy in the
1980s. This clinical failure is attributable to our inability to overcome intrinsic or adaptive resistance in the >30%
of OS patients who fail frontline chemotherapy and develop tumor recurrence, nearly always in the form of lung
metastasis. The tumor microenvironment (TME) is recognized as a key barrier to therapeutic efficacy in solid
tumors. Our overall goal is to understand how cell intrinsic molecular drivers regulate immunologic mechanisms
that shape a metastasis permissive environment in the lung to inform development of both primary anti-
metastatic drugs and co-targeting approaches to potentiate other cancer therapies in OS. We previously
developed a strategy for depletion of metastasis associated macrophages, via blockade of monocyte migration
with oral dosing of a repurposed CCR2 antagonist (losartan), combined with a multi-kinase inhibitor (toceranib),
which resulted in significant clinical benefit (50% response rate) in dogs with spontaneous metastatic OS. Based
on this canine data, this drug combination is currently in a Phase I trial in pediatric OS (NCT03900793).
Our preliminary data suggest focal adhesion kinase (FAK) signaling 1) is an OS cell intrinsic dependency,
2) promotes fibroblast enrichment and pro-tumorigenic function in the OS TME, and 3) that fibroblasts mediate
OS cell resistance to platinum therapy. Therefore, the objective of this proposal is to define the mechanisms by
which FAK signaling in OS tumor cells and lung fibroblasts shapes immune composition of the lung metastatic
TME, and to test whether molecular targeting of FAK improves standard-of-care platinum chemotherapy (SOCC)
response. We hypothesize that a combination of tumor cell intrinsic and lung fibroblast FAK signaling drives a
chemokine secretion profile that mediates a feed-forward loop of increased macrophage recruitment, fibroblast
proliferation, and subsequent T cell exclusion to promote OS metastasis. In Aim 1, we will use a combination of
wild-type and FAK-/- syngeneic and patient-derived OS cells, and fibroblast specific FAK knockout mouse
metastasis models, in parallel with clinically annotated human OS tumors, to define the contributions of tumor
intrinsic and lung fibroblast FAK signaling on chemokine expression, TME composition, and progression of OS
lung metastasis. In Aim 2a, we will leverage dogs with spontaneous OS, the most faithful model of a pediatric
solid tumor, to determine if dual compartment OS cell and TME targeting of lung fibroblasts with a FAK inhibitor
significantly improves the response rate to SOCC. In Aim 2b, we leverage bronchoalveolar lavage, a novel lung
TME monitoring approach developed in our lab and uniquely employable in dogs, and primary tumor multi-omic
profiling, to identify mechanistic predictors of canine patient response to this immunotherapy. Completion of
these studies will inform basic immuno-oncology research in pediatric OS and generate readily translatable data
leading to deployment of this orally administered and clinically well tolerated immunotherapy in a human OS trial.

Public health relevance
Project Narrative Osteosarcoma (OS) is a devastating pediatric cancer for which outcomes have not improved in over three decades due to our inability to prevent or slow lung metastasis in the 30-40% of patients who do not respond to standard-of-care chemotherapy. To address this gap, we will define how an OS cell intrinsic signaling dependency promotes a metastasis permissive lung environment, and leverage dogs with naturally occurring OS, the most faithful model of this cancer, to test an oral immunotherapy drug targeting this signaling and which could be readily implemented in human OS patients. This proposal will also use an advanced immune monitoring technique on samples obtained from the lungs, an innovation developed in our lab, to identify mechanistic predictors of clinical response to this new immunotherapy approach.